Rocky Mountain REACH (RMT-REACH)

PROJECT SUMMARY/ABSTRACT
The L.S. Skaggs Institute for Health Innovation (SIHI)-Research Evaluation and Commercialization Hub (SIHI-
REACH) at the University of Montana (UM) will catalyze the emerging biomedical industry corridor in Montana
and the surrounding states by establishing a hub to accelerate translation of academic discoveries into
products that impact human health. Untapped opportunities exist in IDeA states to turn biomedical research
discoveries into technologies that address unmet medical needs, disease burden, and health disparities for
populations across the United States (US). We have partnered with 10 academic institutions across the IDeA
states in the Washington, Wyoming, Alaska, Montana, and Idaho (WWAMI) region—including a community, a
technological, and a tribal college—as well as the Washington Entrepreneurial-REACH (WE-REACH) at the
University of Washington to gain invaluable guidance from their leadership team. Academic discovery is
indispensable for ensuring a pipeline of research for novel diagnostics, devices, and therapies, yet sustainable
infrastructure to support academic innovators in resource-limited regions has yet to be fully realized.
Geographically remote regions have unique challenges in developing and promoting commercialization and
entrepreneurship, including lack of infrastructure, less access to innovators and subject matters experts, and
lower levels of funding. Gaps in resource allocation contribute to higher rates of mortality and disease burden,
and health systems in these areas have traditionally been late to implement health innovation when compared
to their metropolitan counterparts. In order for health innovation to reach clinical usefulness for all people,
efforts are needed to ensure the inclusion of minority, geographically-isolated, and historically medically
underserved populations at every stage of the biomedical research life cycle. We will accomplish our ultimate
goals through the following aims: 1) Identify emerging biomedical discoveries with commercial viability in
academic institutions within the four regional IDeA states supported by SIHI-REACH, emphasizing discoveries
that address disease burden and health disparities for underserved communities; 2) Develop an innovative
implementation system to enable access to gap funding, key subject matter experts in areas of product
development, regulatory, reimbursement, legal, business development, and overall commercial strategy for
academic researchers in resource-limited areas; 3) Provide funding and project management support for
promising technologies and development teams to accelerate product definition studies; and 4) Elevate a
WWAMI region-wide pro-entrepreneurial culture among academic investigators by engaging and mentoring
biomedical innovators in rural and tribal institutions. With a strong leadership team providing diverse and
complementary expertise and proven experience in entrepreneurial startups, SIHI-REACH will train the next
generation of biomedical innovators in entrepreneurship and product development, positively impact the
regional economy, and bring products that address health disparities to market.
1

Public health relevance
PROJECT NARRATIVE The L.S. Skaggs Institute for Health Innovation (SIHI) Research Evaluation and Commercialization Hub (SIHI- REACH) at the University of Montana will accelerate translation of academic discoveries into products that impact human health in states that have largely not benefitted from investment in commercialization. We have partnered with 10 academic institutions in the Washington, Wyoming, Alaska, Montana, Idaho (WWAMI) region—including a community, a technological, and a tribal college—and are building upon the success of the Washington Entrepreneurial REACH (WE-REACH) at the University of Washington. Participating institutions and innovators will gain access to funding, training, and resources to guide the research and development of new medical products, ultimately fostering a pro-entrepreneurial culture across the region, creating new small businesses, and bringing products to market that address disease burden and health disparities. 1